MIRA: Enzymology and Self-Resistance of Natural Product Biosynthesis

ABSTRACT
Recent progresses in microbial genome sequencing and synthetic biology have created
a renaissance in natural product discovery. This timely combination offers great promise to find
natural products displaying new structures and biological activities. Notwithstanding such
potential, it remains difficult to i) predict product structures directly from biosynthetic gene
clusters (BGCs). This is because our knowledge of enzymes that are involved in natural product
biosynthesis remains limited, especially with regard to the highly programmed enzymes from
eukaryotic organisms such as filamentous fungi; ii) prioritize BGCs that can lead to new-to-
nature chemical structures. This is primarily due to the focus of the field on well-studied natural
product families and core biosynthetic enzymes; and iii) connect the biological activity with
BGCs in genome mining efforts. This represents a gap between genome mining and traditional
phenotypical screen-based discovery in which natural product isolation is guided by biological
activity. This MIRA grant will address these limitations with a comprehensive research program
focused on fungal natural product discovery and biosynthetic investigation.
The first general area of this MIRA project is to gain fundamental understanding of core
enzymes that participate in the biosynthesis of fungal natural products. In particular, we will
focus on understanding the iterative programming rules of fungal PKSs and NRPSs. Other
aspects of core enzyme programming rules, including cyclization and noncanonical domains will
be investigated. We will also investigate the unusual tailoring enzyme activities of fungal
biosynthetic pathways, with emphasis on PLP-dependent and oxidative enzymes. A number of
compound driven biosynthetic investigations will be conducted. The second general area of this
MIRA project is to develop and refine tools for genome mining. The most important research
activity in this area is based on our recently developed resistance gene guided target genome
mining, in which we use an co-clustered, resistant variant of the natural product target in the
BGC as a guide to discover natural product of desired biological activity. This strategy can also
be used to assign biological activities to known natural products. The objectives here are two-
fold: 1) to expand the list of targets that may be identified via resistance gene, to enzymes and
proteins in the central dogma, protein transport, metabolism, etc. Here we will perform genome
mining and/or natural product bioactivity characterization to link metabolites to targets; and 2) to
understand the mechanism of resistance, which will teach us how Nature evolves resistant
enzymes, and refine our understanding of how to overcome potential resistance.

Public health relevance
PROJECT NARRATIVE Genome mining of natural products from sequenced microbial genomes is a promising strategy to new human therapeutics. To increase our abilities in performing genome mining, this MIRA proposal will i) fundamentally understand the enzymology of biosynthetic enzymes that make natural products; and ii) develop more effective methods of mining with a particular emphasis on using resistance enzymes to prioritize biosynthetic pathways that may produce natural products of desired biological activities.